Research Education Component

PROJECT SUMMARY REC
The goal of the UConn OAIC Research Education Component (REC) is to create a new generation of
investigators in aging with exposure to multidisciplinary translational science and expertise in Precision
Gerontology, an area of special emphasis for this proposal. Our goals will be accomplished through 4 aims:
Aim 1: Identify and promote careers of individuals poised to conduct Precision Gerontology research by
providing direct OAIC and matching institutional support together with “in kind” services for 5 Pepper Scholars,
with additional efforts to attract junior investigators and support Emerging Scholars; Aim 2: Provide structured
career development for skills that address the broad range of Precision Gerontology research undertaken at
the OAIC (basic, clinical, health services, and epidemiology) through a broad array of didactic and experiential
offerings, emphasizing multidisciplinary approaches to translation between the bench, bedside and the
community; Aim 3: Provide Coordination and Management Services within the REC and across OAIC Cores
involving access to experienced mentors, feedback, career guidance, direct financial per commitments in
letters from UConn School of Medicine, UConn VP for Research and Jackson Lab plus opportunities to
collaborate with other cores and units within and outside the institution for OAIC-related themes.
The REC will be led by Dr. David Steffens, MD, MHS, Professor and Chair of Psychiatry at UConn Health
who will be assisted by Dr. George Kuchel, MD (REC co-leader; OAIC PI). Both are accomplished mentors,
leaders and leaders in aging research. At the same time, they offer highly complementary backgrounds and
skillsets, thus facilitating the leadership and scientific direction of a REC with a deep commitment to
multidisciplinary team science and translation.
For Year 1, we propose to recruit three highly promising junior faculty as Pepper Scholars. In the application
we describe the wide pool of talent from which we can recruit Pepper Scholars across UConn Health, UConn
Storrs and in the Schools of Nursing, Social Work and Pharmacy. We will aim to recruit a diverse group of
young researchers whose collective expertise and interests reflect the broad goals and ambitions of this
application. The REC will support a total three scholars per year in each of the five years of the project; should
a Scholar graduate from the REC, another will be recruited as a new replacement.